Cancer Research Career Enhancement

Project Summary/Abstract: Career Enhancement
Norris Cotton Cancer Center (NCCC) is a central provider and resource of Career Enhancement activities for
its trainees, Program Members, at both Dartmouth and Dartmouth-Hitchcock Health system (D-H), and
beyond. Importantly, the NCCC Career Enhancement programs link Dartmouth, and the Geisel School of
Medicine, with D-H in the joint endeavor to train the next generation of cancer-focused physicians and
scientists and to improve health locally and globally.
In the last five years, our new initiatives have been responsive to emerging themes, needs and opportunities,
and we have increased our funding base in key areas to implement these initiatives. These new programs
span the breadth of stages of career development and include: 1. Successful founding of the NCI-funded
Dartmouth Opportunities for Oncology Research (DOOR) Training Program for undergraduates from
underrepresented minority (URM) or disadvantaged backgrounds; 2. Implementation of the Training Program
in Surgical Innovation and the Quantitative Biomedical Sciences Graduate Program, both of which are recently
NIH T32-funded and led by NCCC Members; 3. The establishment of two new medical residency programs in
Radiation Physics and Radiation Oncology; 4. Synergistic interaction with the NIH-funded CTSA and COBRE
Programs at Dartmouth to provide mentoring and grant writing support, which has directly contributed to the
doubling of NIH Career Development awards (K and R00) as well as new Komen, American Cancer Society
and NIH MIRA awards, to junior NCCC Members during this reporting period; 5. The expansion of training and
trainee participation in Global Oncology, facilitated by active partnerships with institutions in Honduras and
Rwanda; 6. NCCC has collaborated with Dartmouth, Geisel, and D-H to hire 21 cancer and oncology-focused
faculty within 11 different departments during the current reporting period.
Future activities and goals to facilitate Career Enhancement at NCCC have been prioritized and many are
already underway. Burgeoning initiatives are described within this application and include: integration of a new
Medical Masters in Science Program; the new Radiation Physics residency program underway (2018) and the
Radiation Oncology residency program that will begin next summer (2019); The Translational Oncology
Program Scholars (TOPS) program begins the summer of 2019, and will provide Geisel medical students a
mentored research experience and exposure to clinical translational medicine in order to give an insider’s view
of a career as a translational physician-scientist; and the 2019 launch of the D-H Cancer Faculty Fellows
Program in which six to nine faculty members from the clinical departments will be provided with 40%
protected academic time for 4-year terms to pursue cancer-focused research.